In vivo chemical changes of contemporary polyethylene in TKA: implications for wear and osteolysis

This proposal addresses the unmet need that the mechanisms governing in vivo chemical changes of total
knee arthroplasty (TKA) tibial liners are not known. Our objective is to determine the in vivo chemical alteration
processes of contemporary ultra-high molecular weight polyethylene (PE) tibial liners, their impact on
mechanical and wear behavior, and enhance preclinical methods to predict particle-induced osteolysis in TKA.
The proposed work is significant because understanding how PE changes in the body is essential to
understand long-term PE degradation processes and open new pathways for technology to maximize implant
longevity. This research marks an essential step toward our long-term goal of achieving a lifetime TKA—
independent of patient age. Our central hypothesis is that initial PE structure, implant design, and the chemical
periprosthetic environment drive in vivo oxidation, mechanical properties, wear, and thereby the onset of
osteolysis. We base our hypothesis and approach on our preliminary data of TKA wear assessment, validated
FEA-based wear simulation, chemical and mechanical characterization of PE, and FTIR imaging (FTIR-I)
augmented histopathological analysis. We will test our hypothesis with three Specific Aims. Aim 1. To
determine PE mechanical in vivo changes and their impact on TKA long-term wear behavior and damage
progression. Working Hypothesis: The initial PE structure and tibial liner design drive the rate, quantity, and
spatial distribution of in vivo mechanical properties changes. We will test the hypothesis using retrieval
analysis, bench tests, and FEA which simulates tibial liner wear and damage after oxidation-induced
mechanical properties changes. Aim 2. To determine the onset and progression of late osteolysis in
contemporary TKA in a large retrieval cohort by means of FTIR-I augmented histopathological evaluation.
Working hypothesis: osteolysis onset and progression will be prevalent in otherwise well-functioning TKAs as
seen by radiolucencies and FTIR-I augmented histopathological markers within periprosthetic tissue at 12-15
years in situ. Aim 3. To determine PE chemical in vivo changes and the impact of the local periprosthetic
environment. Working hypothesis: Competitive absorption of pro-/anti-oxidative constituents from the
periprosthetic environment accelerates PE oxidation and changes in mechanical/tribological properties. A
novel FEA model will be used to simulate competitive absorption, verified with FTIR-I/Raman scans of
retrieved liners. The proposed research is innovative because it focuses on the relationship between oxidation,
in vivo exposure of tibial liners to pro- and anti-oxidative species, in vivo loading, and the relationship to PE
type (dose and thermal treatment). It will also investigate new techniques for identifying PE within
periprosthetic tissues. This new and substantively different approach will open new horizons to minimize in vivo
PE oxidation, diagnose PE-induced inflammatory responses, and predict implant longevity.

Public health relevance
The proposed research is relevant to public health because improving the longevity of total knee arthroplasty would help the over 750,000 patients undergoing knee replacement annually by ultimately helping to delay or avoid revision surgeries. The proposed research is relevant to the NIH mission by 1) reducing the burden of human disability by improving the quality of life of total knee arthroplasty patients and 2) reducing the cost of medical care by preventing revision surgery.